ADMINISTRATIVE CORE

A. Specific Aims The Administrative Core (AC) will provide support for planning, execution, and evaluation of the proposed research. The AC will support all administrative activities relating to the five projects and high throughput core enabling cohesion among the projects.